Cortical Interneuron Dysfunction in Fragile X Syndrome

SUMMARY
Cortical circuit dysfunction is a primary pathophysiology that underlies prominent neurological symptoms of
Fragile X Syndrome (FXS). Yet the precise way in which circuit development in the cortex is altered in FXS
has not been fully elucidated. Recent work by us, and others, has established that local circuit interneurons
(INs) may be a key to understanding cortical circuits in FXS. We demonstrated that the density, maturity
and activity of parvalbumin (PV) cortical INs are all reduced in the Fmr1 knockout (KO) mouse model of
FXS. Here we propose to address outstanding questions in the field by determining how the birth, migration
and connectivity of PV INs are disrupted in Fmr1 KO mice, and how this leads to sensory hypersensitivity
and tactile defensiveness. We will incorporate a detailed analysis of PV INs using birth dating,
neuroanatomical and functional studies to define how the abnormal integration of PV INs into feedforward
circuits in the primary somatosensory cortex (S1) contributes to atypical sensory processing. In preliminary
studies, we demonstrate that, in response to repetitive whisker stimulation, Fmr1 KO mice display
maladaptive avoidance behaviors that correlate with a lack of neuronal adaptation of layer (L) 2/3 pyramidal
neurons in S1. We also show that PV INs and their precursors from the medial ganglionic eminence (MGE)
are hypoactive in S1 of Fmr1 KO mice by postnatal day (P) 6, and that increasing their activity for a few
days using excitatory DREADDs significantly increases their density by P15. We will now determine whether
similar early activity manipulations of MGE-derived INs, or later on in more mature PV INs, can restore the
loss of sensory adaptation of L2/3 neurons and ameliorate tactile defensiveness in Fmr1 KO mice. We will
address the following important questions: 1. What are the contributions of neurogenesis, migration,
connectivity and developmental apoptosis to the reduced density of PV INs in FXS? 2. How do MGE-derived
INs and pyramidal neurons interact during the early postnatal critical period and how is their ‘handshake’
different in FXS? 3. Is the hypoactivity of PV INs or their precursors causal to the circuit and behavior deficits
of Fmr1 KO mice? The mechanistic experimental design employs cell type-specific intersectional genetics,
in vivo calcium imaging, chemogenetics, and ex vivo circuit channel-rhodopsin connectivity mapping, among
others. An important goal of this grant is to identify whether targeting INs is a viable path for therapeutics in
FXS. As such a novel class of allosteric modulating drugs of Kv3.1 channels (responsible for fast-spiking
characteristics of PV INs) will be tested in Fmr1 KO mice. Overall, the collaboration between the laboratories
of Dr. Carlos Portera-Cailliau (co-PI, PL) at UCLA and Dr. Anis Contractor (co-PI) at Northwestern University
will enable a comprehensive approach to understanding the developmental and functional contributions of
INs to the pathophysiology of FXS.

Public health relevance
NARRATIVE Fragile X syndrome (FXS) is a devastating neurodevelopmental disorder with prominent sensory hypersensitivity that negatively impact the quality of life of individuals. These studies will determine how the formation and function of brain circuits that underlie this are disrupted in a mouse model of FXS. Ultimately, our translational studies in mice will test new classes of treatments to alleviate sensory symptoms in FXS.